Role of the retinoic acid pathway during graft-versus-host disease

Graft-versus-host disease (GVHD) remains the most significant obstacle to the broader application of allogeneic hematopoietic stem cell transplantation (HSCT), a life-saving treatment for many malignant and nonmalignant diseases. It is mediated primarily by donor T cells that cause multi-organ damage, including the skin, liver, and gastrointestinal tract in HSCT recipients. Of these target organs, the gastrointestinal tract is of particular clinical and immunological significance. Indeed, severe intestinal damage is largely responsible for the GVHD-associated deaths in patients and experimental animals. However, the cellular and molecular mechanisms underlying the inflammatory responses in the GI tract during GVHD remain unclear. Our long- term goal is to develop clinically based strategies to prevent or mitigate intestinal damage during GVHD, thereby improving the outcomes of allogeneic HSCT. We recently identify retinoic acid (RA), the active metabolite of vitamin A, as a key molecule in facilitating the development of intestinal GVHD. Specifically, administration of exogenous RA exacerbates gut damage in recipient mice and significantly increases GVHD- associated mortality. Importantly, donor T cells from the retinoic acid receptor (RAR)-α deficient mice show markedly diminished ability to cause lethal GVHD and, more specifically, intestinal damage. These novel findings identify an organ-specific role of RA in GVHD and provide evidence that the RA pathway is critically involved in the pathogenesis of intestinal GVHD. The objective of this proposal is to address clinically relevant questions with respect to how the RA pathway controls intestinal GVHD development and whether manipulating this pathway can reduce disease severity. We hypothesize that the RA pathway is critical for host and donor dendritic cells to initiate and perpetuate intestinal GVHD and this pathway can be manipulated for therapeutic purposes. We will combine genetic, nutritional, and pharmacological approaches to examine the hypotheses. In Aim 1, we will determine how RA production and RAR signaling are altered after allogeneic HSCT. We will then examine how these changes affect the function of host and donor dendritic cells to cause intestinal GVHD. Aim 2 will determine if manipulating the RA pathway is a novel approach to prevent and/or treat intestinal GVHD. We will examine if pharmacological blockade of the RA pathway using novel small molecule inhibitors can prevent intestinal GVHD. We will also explore if RA-programmed regulatory T cells can be used to treat established intestinal GVHD. Finally, we will determine whether the critical graft-versus- leukemia effect is preserved using these approaches. We expect that insights gained from these studies will contribute to a better understanding of the fundamental role of the RA pathway in the pathophysiology of intestinal GVHD and provide preclinical data to develop novel strategies to prevent or treat this devastating complication after allogeneic HSCT.

Public health relevance
The proposed research is relevant to public health because graft-versus-host disease (GVHD) is the major complication of allogeneic stem cell transplantation (HSCT). Elucidation of the role of the retinoic acid pathway in intestinal GVHD offers the potential to mitigate disease in this critical tissue site and thereby reduce overall mortality in allogeneic stem cell transplant recipients.